Mechanism of GDNF Regulation of Hepatic Steatosis

Non-alcoholic fatty liver disease (NAFLD) is a common cause of chronic liver disease in veterans and its
prevalence continues to increase, with the growing obesity epidemic. Currently more than 25% of our veterans
are obese and a larger number are overweight. In this proposal, we will examine the pleiotropic effects of Glial
Derived Neurotrophic Factor (GDNF) on hepatocytes. We have demonstrated that GDNF transgenic (GDNF-
Tg) mice fed a high fat diet are protected from obesity and the development of hepatic steatosis despite similar
food intake and physical activity. GDNF-Tg mice overexpress GDNF under the control of the GFAP promoter
expressed in glia and stellate cells. GDNF and its receptor GFRα−1 are expressed in human and murine
hepatocytes. Thus, GDNF present in the liver can act locally on the hepatocytes. We recently demonstrated
that GDNF can enhance autophagy and prevent liver injury. Our preliminary data demonstrate novel effects of
GDNF on the liver that include: (i) Human liver tissue from patients with steatosis and fibrosis have reduced
GDNF expression (ii) Western diet (WD)-fed mice have reduced level of Sirt3 and this is ameliorated in GDNF-
Tg mice fed a WD; (iii) Human hepatocytes treated with GDNF have increased mitophagy. (iv) GDNF prevents
apoptosis in primary human hepatocytes. The signaling pathway for these potentially beneficial effects of
GDNF have yet to be explored. We hypothesize that the mechanism of GDNF prevention of hepatic injury is
through promoting hepatocyte Sirt3 signaling, subsequent improved mitochondrial function leading to
increased hepatocyte survival. Using both genetic and pharmacological approaches we will define the role of
GDNF in inducing mitophagy to lead to improved mitochondrial function, fat reduction and reduced hepatic
injury. To test the hypothesis and further investigate the underlying mechanism(s) of GDNF regulation of
hepatic steatosis, we propose the following interrelated, but independently achievable aims: Specific Aim 1:
To determine the mechanism of GDNF regulation of Sirt3 Preliminary data indicate that GDNF is a potent
inducer of Sirt3 in vivo and in vitro. We have demonstrated that GDNF can activate the ERK signaling pathway
in hepatocytes through its receptor GFRα1. We will establish if the mechanism of GDNF regulation of Sirt3 is
through the GFRα1-ERK-CREB-PGC-1α pathway. WT and GDNF-Tg mice will be fed a Western diet together
with fructose and glucose added in drinking water (WD/FG) for 16 weeks and ERK-CREB-PGC-1α-Sirt3
pathway assessed in hepatocytes. In vitro the necessity and sufficiency of ERK-CREB-PGC-1α in the GDNF
regulation of Sirt3 expression will be determined using gene knock down and overexpression strategies.
Specific Aim 2: To examine the role of mitochondrial function and mitophagy in GDNF-mediated
hepatocyte survival. Our preliminary data demonstrate that GDNF increases mitochondrial function and
mitophagy in hepatocytes. We will establish the role of GDNF in regulating mitochondrial function and
mitophagy using the GDNF-Tg mice and in vitro experiments involving treatment of hepatocytes with GDNF.
We will examine the mechanism of GDNF regulation of mitochondrial health using gene knock down and over-
expression strategies. We will examine the role of GDNF-induced mitophagy in regulating hepatocyte survival.
Specific Aim 3: To establish that GDNF-loaded ginger lipid nanoparticles can prevent hepatic lipid
accumulation and promote hepatocyte survival. Our preliminary data demonstrate our ability to generate
liver-specific natural ginger nanoparticles. We will examine the effect of GDNF-loaded ginger nanoparticles on
hepatic steatosis and hepatocyte cell death and injury. GDNF-loaded ginger nanoparticles will be injected once
a week into WT, Sirt3 KO mice and PINK1 KO to further establish the mechanism of action of GDNF involving
Sirt3 and PINK1. Taken together our data from this proposal may provide novel targets for the treatment or
prevention of hepatic steatosis and injury.

Public health relevance
Non-Alcoholic Fatty liver disease is a major health problem for veterans. It involves the accumulation of fat in the liver known as hepatic steatosis. It is seen in obese patients. Glial cell line-derived neurotrophic factor (GDNF) may play an important role in the prevention or treatment of hepatic steatosis. Experiments outlined in this proposal will study the mechanism of how GDNF regulates hepatic steatosis. These experiments will not only contribute to the understanding of the mechanisms of regulation of hepatic steatosis, but may also lead to new therapeutic targets for its prevention and treatment. Impact on Veterans Health Care: Hepatic steatosis is highly prevalent in the Veteran population and the incidence is rising. Results from this study can help veterans by identifying new targets to prevent and treat obesity related liver diseases like steatosis.